Advancing lymphatic filariasis elimination with parasite genomic epidemiology

Project summary
Lymphatic filariasis (LF) is a mosquito-borne infection caused by filarial nematodes, leading to acute fever
attacks and long-term disability due to hydrocele, lymphedema, and elephantiasis. The Global Program to
Eliminate Lymphatic Filariasis (GPELF) is the largest public health intervention initiative based on mass drug
administration (MDA), aiming to interrupt the parasite lifecycle by treating the at-risk population with drugs that
clear transmissible first stage larvae (microfilariae, mf) in the human host. Despite years of MDA, LF transmission
persists or has resurged in some countries that were deemed to have reached elimination targets, threatening
the World Health Organization’s elimination goals. To mitigate this risk, understanding the various causes of
infection resurgence is essential, and closing this knowledge gap is our focus.
Current measures of infection, which rely on counting mf in blood (since adult filariae are not directly
accessible) or detection of circulating filarial antigen, cannot differentiate between recrudescence and reinfection,
or determine the origin of transmission. We recently demonstrated that a comprehensive full-genome analysis
of individual mf from Wuchereria bancrofti infected individuals enables (a) estimation of the number of
reproductively active females, (b) genetically tracking these maternal lineages through treatment, and (c)
differentiation between recrudescence and reinfection. This prior advancement facilitates determination of
parasite population genetics among hosts and geographies. In this proposal, we will test our overarching
hypothesis that by reconstructing sibling relationships in longitudinal mf samples and performing genomic
characterization in geospatial mf samples it is possible to monitor the number of reproductively active adult
females, differentiate new and established maternal families, and understand the population dynamics in
elimination contexts. Analyzing longitudinal samples provides insights into temporal changes in the parasite
population (Aim 1), while analyzing geospatial samples identifies transmission sources (Aim 2). Together, these
analyses will elucidate the causes of persistent or resurgent infections and enable the generation of evidence-
based empirical parameter estimates for transmission modeling (Aim 3) to determine the likelihood and pace of
resurgence, supporting identification of the optimal surveillance strategies.
Collectively, the results of our research will link newly generated population genetic information to
transmission dynamics modelling to predict the risk that parasite migration and/or resurgence (or poor treatment
response) will impede W. bancrofti elimination.

Public health relevance
Project narrative The World Health Organization's elimination goals for lymphatic filariasis are threatened despite years of mass drug administration. To mitigate the risk, understanding the various causes of infection resurgence is essential. We will develop and deploy molecular genetic approaches that differentiate between recrudescence and new infection, assess the likelihood of resurgence of infection based on transmission patterns and trace the likely source of parasite reinvasion. By integrating these data into a refined epidemiological model of lymphatic filariasis, we seek to maximize the value and impact of these data to inform strategies for managing resurgence and support programmatic decisions.